Heterochromatin as a barrier to regeneration in the mouse cochlea

PROJECT SUMMARY/ABSTRACT
The main cause of hearing loss is damage of cochlear sensory hair cells within the inner ear. The long-term
objective of the Segil lab is to treat human deafness through the regeneration of lost sensory hair cells within the
organ of Corti. A potential strategy for hair cell regeneration is to induce surviving supporting cells in long-
deafened inner ears to transdifferentiate into new functional hair cells.
In early perinatal mice, upregulation of the hair-cell specific transcription factor ATOH1, or disruption of Notch
lateral inhibition in supporting cells, is sufficient to induce transdifferentiation. However, supporting cells quickly
lose the potential to transdifferentiate within one week after birth. The loss of this plasticity may be due to
epigenetic maturation, wherein the spread of heterochromatin in perinatal supporting cells represses hair cell-
specific gene regulatory networks required for transdifferentiation. Heterochromatin are highly condensed
regions of nuclear DNA associated with gene silencing, and it has cell-type specific characteristics that acquires
during development. Epigenetic marks of heterochromatin include DNA methylation, H3K9 methylation, and
H3K27 methylation.
My preliminary data shows that blocking DNA methylation is sufficient to prolong the window of
transdifferentiation potential in postnatally maturing supporting cells. Additionally, I have shown that SCs
gradually gain DNA methylation as they mature from P1 to P21.
This project hypothesizes that postnatally maturing supporting cells gain heterochromatin-associated DNA
methylation and H3K9 methylation to repress hair cell gene regulatory networks required for transdifferentiation.
Aim 1 will characterize the changes in DNA methylation between postnatal day 1 and 6-week old supporting
cells of the organ of Corti, as well as test the DAPT-induced transdifferentiation response after blocking DNA
methylation gain. Aim 2 will examine the changes in H3K9 methylation between postnatal day 1 and 6-week old
supporting cells, as well as test the DAPT-induced transdifferentiation response after blocking H3K9 methylation
gain. These two aims will elucidate how the spread of heterochromatic features in postnatally maturing
supporting cells may contribute to the loss of transdifferentiation potential, which will which will guide future
endeavors to regenerate hair cells and restore hearing.

Public health relevance
PROJECT NARRATIVE Age-related hearing loss affects roughly half of adults over 65 and can have a significant impact on quality of life. Currently, there are no regenerative therapies available for hearing restoration. This proposed research will identify potential barriers to regeneration within the inner ear to inform new therapeutic strategies for human deafness.